Evaluating Differences in Innate Immune Response to Highly Pathogenic H5N1 Viruses

Abstract
H5N1 Highly Pathogenic Avian Influenza virus (HPAIV) spreads globally through migratory birds. Outbreaks of
avian influenza cause significant financial losses for particularly for the poultry and dairy industries. The first
human infection with HPAIV H5N1 was in 1997, followed by an additional 17 cases and a total of 6 deaths. Since
2003, there have been over 900 human cases with a mortality rate exceeding 50 percent. Currently, no effective
vaccine is available, and Tamiflu does not work well against clade 2.3.4.4b H5N1. It is pivotal to understand the
risk of the virus acquiring efficient cross-species transmission and further sustained human-to-human
transmissibility. Adaptive mutations have emerged during infection of humans and a broad spectrum of mammals,
posing a huge threat to public health. As a host restriction factor, myxovirus resistance 1 (Mx1) protein is
recognized as a crucial gatekeeper candidate. Studies have shown Mx1 protein exhibits antiviral activity against
HPAIV H5N1. The proposed research will test the hypothesis that different H5N1 isolates have different
sensitivity to different Mx1s, which is associated with mutations of the viral genome. Preliminary data
showed that murine Mx1 (muMx1) provides impressive resistance against H5N1 infection. Mx1 expression
increased the lethal dose by at least 1000-fold when comparing that between wild type B6 and Mx1 (+/+) A2G
mice. Meanwhile, the Mx1 sensitivity differs significantly between a human isolate and a sea lion isolate, carrying
limited variation between two viral genomes. I will test the sensitivity of different H5N1 viruses to muMx1 in vivo
and investigate any correlation to specific genotypic polymorphisms (Aim 1). It is anticipated that the data will
show different H5N1s carry different muMx1 sensitivity. Based on the genome alignment, the genomic
determinant will be identified and related to Mx1 sensitivity. I will investigate the impact of these new biomarkers
on virus sensitivity to Mx1. The results will provide insight into the risk of H5N1 breaking the species barrier with
novel genetic markers. Additionally, I will assess the sensitivity of H5N1 viruses to Mx1 from different hosts in
vitro, serving as a tool to assess potential host range (Aim 2). A549 STAT1 knockout cell line will be used as a
platform to express exogeneous Mx1 proteins to examine Mx-mediated antiviral phenotype. It is anticipated that
the results will show viruses from different hosts display different Mx1 sensitivities, indicating each virus has its
own susceptible hosts. This Mx1 library can be expanded with new Mx sequences from mammalian species of
interest, assessing the potential transmissibility of certain H5N1s among different mammalian species. The
overall project will provide risk assessment of the current HPAIV H5N1 to public health and in vitro and in vivo
models for the future study. Completion of this proposal will provide training in (1) advanced molecular biology
approaches, (2) virology concepts and methods, (3) next generation sequencing skills, (4) mass spectrometry
techniques, and (4) biosafety procedures for working with select agents – equipping me with essential expertise
needed to develop an independent research program on emerging infectious diseases.

Public health relevance
Narrative Highly Pathogenic Avian Influenza viruses (HPAIVs) H5N1 have over 50% mortality rate in human and myxovirus resistance 1 (Mx1, MxA in human) protein is a crucial gatekeeper candidate against cross-species transmission. The viruses with random spillover from avian to mammals acquire the mutations against Mx1 resistance, and the accumulative of such mutations would cause efficient cross-species transmission. By leveraging Mx1 in vivo and in vitro models, this proposal will evaluate Mx1 sensitivity of current H5N1s and identify the novel mutations against Mx1 resistance, which demonstrates steadily cross-species transmission risk.